Neural Mechanisms of Irritability: A Dimensional Approach with Integration of Multi-Voxel Pattern Analysis and Univariate Analysis

Chronic, clinically-impairing irritability is a serious health problem that affects 3-5% of youth and predicts both adult depressive and anxiety disorders and long-term impairment. Current studies on the neural mechanisms of irritability in youth employ traditional univariate analyses and have limitations: (1) they examine activation patterns in particular regions, thus using only a small portion of the data and (2) they tend to find small to moderate effect sizes. In addition, little is known about functional connectivity at rest and its association with irritability or the ability of neural measures to predict changes in irritability over time. These limitations could be addressed through research using multi-voxel pattern analysis (MVPA), i.e., by applying machine learning methods to both resting state and task-based fMRI data. MVPA exploits the full spatial pattern of brain activity and thus has increased sensitivity compared to conventional univariate, individual-voxel-based general linear model (GLM) approaches. However, univariate analyses may provide complementary or unique information relative to MVPA, given its sensitivity to variability and global engagement of task effects between subjects. The specific aims of this project are to identify patterns of whole-brain activation (Aim 1 & 2a, 2b) and functional connectivity at rest (Aim 2a, 2b) using a combination of MVPA and univariate approaches to predict (1) individual differences in irritability in a clinical sample of youth and in healthy youth with varying degrees of irritability, and (2a) individual differences in irritability and (2b) changes in irritability 6 months later in a community sample of youth with varying degrees of irritability. This work will provide new insights into the pathophysiology of multiple mental disorders for which irritability is an important symptom, and it has the potential to identify biomarkers that can be used to predict the course and prognosis of clinically-impairing irritability. The long-term goal of the PI is to become an independent NIH-funded investigator with a neuroscience-focused research program targeting developmental trajectories of irritability. To achieve this goal, the PI aims to expand her previous training to support both advanced, independent research on resting state and task-based fMRI and the use of pattern classification techniques, as well as their integration with univariate methods, applied in samples with varying degrees of irritability. This training objective directly supports the PI’s research objective, which is to identify the neural mechanisms of irritability and neural correlates that predict changes in irritability over time using a combination of MVPA and univariate imaging methods applied to task-based and resting state fMRI data. The central hypothesis, based on the PI’s pilot data, is that activity patterns during a frustration task, along with connectivity patterns at rest, will predict levels of, and changes in, irritability. Both univariate and MVPA approaches will converge on similar findings; however, MVPA will identify additional activation and connectivity patterns predictive of irritability or changes in irritability. The training objectives for this award are to enhance the PI’s research and professional skills and knowledge in three areas: (1) phenotyping clinically-impairing irritability; (2) task-based and resting state fMRI methods, designs, preprocessing, and advanced MVPA techniques, i.e., machine learning for analyzing fMRI data, and their integration with univariate analyses; and (3) professional skills essential for a successful research career as a faculty member at a research university. By completing the proposed research and training, the PI expects to obtain sufficient training to function as an independent developmental affective neuroscientist, and sufficient pilot data to submit a competitive R01 application designed to examine predictors of developmental changes in pediatric irritability across multiple levels of analysis from neural circuits, behaviors, social experiences, to environmental factors.

Public health relevance
The proposed project is relevant to public health because impairing irritability affects approximately 2.5 million youth in the U.S., and is a relatively common source of concern for clinicians, parents, and teachers. Clinicallyimpairing irritability in youth has been linked to adult psychopathology and is among the strongest predictors of suicidality across the life span. A better understanding of the neural markers underlying irritability and changes in irritability has significant potential to inform a better diagnostic classification system and to provide biomarkers for making treatment decisions, monitoring treatment responses, and predicting the developmental course of irritability.